Cell signaling in regeneration and tissue scaling

Project Summary/Abstract
Organisms with regenerative abilities have been informative models for uncovering natural mechanisms by
which tissue damage activates stem or progenitor cells for injury repair. The timing, location, and extent of
injuries are not predetermined, requiring the existence of mechanisms that instruct tissue restoration activities
that perfectly counter the effects of damage. A key question to understand this process is how regenerative
tissue redefines territories removed by injury, and it is hypothesized this is related to as-yet undiscovered
systems that robustly regulate tissue proportionality across large length scales. To begin to address this
question, it is essential to define the cell signaling systems that underlie regional identity and proportional
growth. While regenerative tissues have been extensively probed for the roles of injury-induced signals and the
involvement of stem or progenitor cells, much less is known about the molecular and developmental processes
that enable the restoration of form after injury and its maintenance through adult growth. In the aims of this
grant, this deficit is addressed by leveraging expertise in the planarian system, which uniquely allows for the
study of signaling that regulates re-scaling of tissues through regeneration, to elucidate the regulatory and
developmental mechanism that generates and restores tissue proportionality after injury. Uncovering
fundamental mechanisms used by organisms to control tissue proportionality will provide foundational insights
into understanding diseases of growth misregulation, the nature of proportional growth, and the control of stem
cells for tissue regeneration.

Public health relevance
Project Narrative Organisms capable of tissue regeneration after injury offer natural biological solutions to the problem of how stem cell activities can be controlled to repair damaged organs. An essential driver of regenerative must be mechanisms that enable the detection of damaged or missing tissue that instruct precise repair. The goal of the proposed project is to elucidate how organisms control and use spatial information about tissue position and proportionality for regeneration, providing insight into the ways that adult growth can be disrupted in disease or controlled for tissue repair.